OPIOIDS, AMPHETAMINE &COCAINE IN DRUG ABUSE

A considerable research effort has been made to characterize the central effects of daily administration of drugs of abuse. It has been shown that the motor stimulant effect of amphetamine, cocaine and opioids is progressively enhanced after daily administration. With the exception of amphetamine, relatively little experimentation has been conducted to characterize behavioral "sensitization" to cocaine or opioids in terms of alterations in dopaminergic function. Evidence is presented to suggest that a change in the dopamine (DA) neurons in the A10 region may underlie some aspects of behavioral sensitization. Therefore, neurochemical studies will focus on this brain region, as well as the nucleus accumbens, prefrontal cortex, striatum and A9 DA region. This proposed research will characterize the effects of daily administration of cocaine, ip, morphine, ip, enkephalin analogues, intra-A10, and stress on central DA systems. Rats will receive daily administration of these drugs or stress, and at various times afterward in vitro and postmortem studies will be performed, including measurement of basal and induced DA released from tissue slices, and measurement of DA metabolism, dopa accumulation and DA depletion after tyrosine hydroxylase inhibition. In addition, in vivo measurement of DA release will be assessed using voltammetery and intracranial dialysis. Once changes in dopaminergic function produce by daily exposure to drugs of abuse and stress have been defined, the capacity of daily treatment with one drug to alter the behavioral and neurochemical effects of another drug or stress (i.e. cross-sensitization) will be examined. These studies are designed to determine if a common dopaminergic mechanism may be mediating behavioral sensitization to the daily treatment of cocaine, opioids and stress. Cocaine abuse has markedly increased in recent years, and simultaneous opioid and cocaine abuse appears to be on the rise. Thus, the proposed studies will contribute not only to our understanding of the neurochemical consequence of cocaine and opioid abuse, but how parallel abuse of the drugs may synergize. While a role by stress in promoting drug abuse remains ill- defined, an interaction with DA systems in common with that of drugs of abuse would support such a role.